17th International Conference on Endothelin: Physiology, Pathophysiology and Therapeutics

17th International Conference on Endothelin: Physiology, Pathophysiology and Therapeutics Project Summary/Abstract The purpose of this proposal is to seek support for the virtual APS Conference entitled “17th International Conference on Endothelin: Physiology, Pathophysiology and Therapeutics” scheduled for October 4-7, 2021. The objective of this conference is to review current basic, translation and clinical research on the importance the endothelin system in health and disease. The conference will bring together internationally renowned scientists working in the endothelin field, as well as related interdisciplinary fields, to exchange and disseminate research findings. This meeting was last held in 2019 in Kobe, Japan and some major clinical advances have been made in the last 2 years. The program will be organized into four distinct modules in endothelin research: renal and cardiovascular physiology and pathophysiology, novel regulatory pathways, neurology and pain, cancer and immunology. There will be invited talks by early stage and senior investigators that will be intermingled with abstract selected presentations from all career stages. There will also be two poster session which will have “on call times” for presenters to give their 3 min poster presentation followed by a Q&A period. Moreover, there are virtual breakout rooms to promote in-depth discussions among trainees, young scientists and established investigators. The conference will bring together internationally renowned scientists to exchange ideas, develop scientific relationships, and promote collaboration in a virtual platform. The meeting will have a strong emphasis on trainee involvement.

Public health relevance
17th International Conference on Endothelin: Physiology, Pathophysiology and Therapeutics - Project Narrative The purpose of this proposal is to seek support for the virtual APS Conference entitled “17th International Conference on Endothelin: Physiology, Pathophysiology and Therapeutics” scheduled for October 4-7, 2021. The meeting has a strong emphasis on the use of endothelin receptor antagonists to treat a wide range of diseases affecting all organ systems. Clinical and basic science endothelin research has made important contributions to improving human health and this conference is the premier opportunity to share key, important discoveries in the field every two years.